Sex-dependent functions of spinal dopamine 1 receptors in neuropathic pain

Chronic pain is more prevalent in women, and the rapidly increasing list of mechanistic sex differences in pain signaling
has underscored the importance of considering sexual dimorphism in the development of therapies for chronic pain
management in women. Our long-term goal is to investigate sex differences in spinal dopaminergic mechanisms
of persistent pain. The objective of this exploratory project is to define dorsal horn (DH) Drd1-expressing neurons
and the function of Drd1 in a model of neuropathic pain. Our central hypothesis is that Drd1 participates in nerve
injury-induced hypersensitivity in a sexually dimorphic manner due in part to differential expression in DH
neuronal subpopulations in male and female mice. Preliminary electrophysiological recordings demonstrate a
striking difference in the distribution of firing patterns of Drd1-expressing DH neurons in males and females. This
observation suggests sex differences in the expression of Drd1 among subsets of DH neurons that could
contribute to sex differences in spinal dopaminergic signaling under conditions of persistent pain. Drd1 is
expressed in a heterogeneous population of excitatory and inhibitory DH neurons and partially overlaps with
markers of excitatory subpopulations that participate in tactile hypersensitivity. Therefore, excitatory Drd1
neurons may participate in DH circuits, mediating nerve injury-induced hypersensitivity. On the other hand,
increased activation of DH Drd1 inhibitory neurons may contribute to disinhibition-mediated hyperexcitability
under conditions of persistent pain. We will address the potentially distinct functions of Drd1 in excitatory and
inhibitory neurons using intersectional deletion of the receptor. The overall rationale for the proposed research
is that it will identify specific mechanisms contributing to sex differences in spinal dopamine signaling, which
could be harnessed for more effective chronic pain management in women. In Aim 1, we will identify the pattern
of Drd1 distribution among subsets of DH neurons in males and females. We will use fluorescent in situ hybridization
analysis to determine the expression of Drd1 in transcriptionally defined subtypes of DH neurons. We will also
define the firing patterns and primary afferent inputs of excitatory and inhibitory Drd1 neurons using patch clamp
electrophysiology and will label recorded neurons with neurobiotin for neuroanatomical analysis. In Aim 2, we
will define the contribution of Drd1 in excitatory and inhibitory DH neurons to nerve injury-induced hypersensitivity
in males and females, using an intersectional AAV-mediated CRISPR/Cas9 gene ablation approach; we will
determine the functional impact of Drd1 ablation behaviorally. Impact: The proposed project will advance
understanding of the mechanisms that underlie sex differences in chronic pain by elucidating the function of Drd1
in nerve injury-induced hypersensitivity in female and male mice. This outcome will provide proof-of concept for
comprehensive investigation of sex differences in spinal dopamine signaling, extending to 1) other persistent
pain models, 2) the other dopamine receptors, which are also expressed in spinal cord, and 3) the descending
dopaminergic inputs, which originate in hypothalamus and have been implicated in pain chronification.

Public health relevance
Chronic pain conditions, including back pain, arthritis and headache, are a major health problem in the United States and worldwide, and new safe medications are urgently needed. Chronic pain is more prevalent in women, and understanding these differences is critical for ensuring effective pain management in women. The goal of the proposed project is to determine if dopamine 1 receptors in the spinal cord play a greater role in chronic pain in females than in males.